Targeting scaffolding proteins to disrupt radioresistance in glioblastoma

PROJECT SUMMARY
Glioblastoma (GBM) is an aggressive brain cancer type that responds poorly to standard treatment and ultimately
develops chemo- and radioresistance. This is due, in large part, to the presence of a sizable and heterogeneous
population of GBM stem-like cells (GSCs) that escape conventional therapies and replenish the tumor mass.
This project addresses the dire need of attacking these resilient GSCs in order to improve GBM therapy. We will
pursue a novel approach focused on targeting cell-scaffolding proteins that are essential for cellular functions.
Because GSCs rely on these scaffolding proteins to maintain signaling mechanisms that are critical to
radioresistance, we expect that our approach will create an inescapable vulnerability to the effects of radiation,
achieving significantly increased tumor lethality. We will focus on a cell-scaffolding protein of the DLG (Disc
Large Homologs) family, which are protein-carriers that are critical to keep signaling mechanisms active in their
correct locations within the cell. We recently discovered that an unusual member of this family, DLG5, is highly
upregulated in GBM and is necessary to maintain the GSC population in the tumor. Our published and
preliminary work shows that DLG5 keeps tumor stemness and radioresistance mechanisms, such as Sonic
Hedgehog (Shh) and Hippo, in a persistently active state. Accordingly, our central hypothesis is that DLG5
maintains redundant mechanisms that contribute to tumor stemness and the resistance of GSCs to radiation.
We predict that targeting of DLG5 will create a non-recoverable vulnerability that can be combined with
radiotherapy for improved attack of GBM. To validate this hypothesis, our first Aim is to characterize how the
genetic targeting of DLG5 sensitizes GBM cells to radiotherapy. We will investigate the regulation of
complementary Shh/Hippo signaling by DLG5 in GSCs and will determine if DLG5 deficiency causes a dominant
negative effect that synergizes with radiation to kill these tumor cells. Phenotypic and mechanistic studies will
be pursued in GSC cultures, followed by studies in tumor organoids and in vivo orthotopic GBM models. Our
second Aim is to validate new agents to disrupt DLG5 functions and radioresistance in GBM. We will engineer
cells with DLG5 deletion constructs to identify DLG5 domains that are critical to keep active Shh/Hippo signaling
and to maintain the radioresistant features of GSCs. Next, we will focus on our described interaction of DLG5
with the ubiquitin-ligase cullin-3, which is "sequestered" by DLG5 in order to keep stemness pathways in a
persistently active state. We will test novel cell-penetrating peptides designed to disrupt the interaction of these
two proteins, with the expectation that releasing cullin-3 from DLG5 will result in dominant negative effects on
radioresistance. Successful completion of this exploratory project will demonstrate the importance of cell-
scaffolding proteins as high-level targets that can be disrupted to create an inescapable vulnerability in the tumor
stem cell population, increasing the lethality of radiotherapy and other conventional treatments. Targeting
scaffolding proteins can open new avenues to develop medicines with high therapeutic impact against GBM,
improving the survival of patients with this aggressive cancer.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Glioblastoma is a very aggressive tumor of the Central Nervous System that responds poorly to conventional treatments and develops resistance to chemo- and radiotherapy. In this project we will investigate a novel mechanism that contributes to tumor cell survival and resistance to radiation; we will also develop novel agents to disrupt this mechanism and make glioblastoma more sensitive to radiotherapy. Our research will identify effective strategies to weaken the tumor, contributing to more effective treatments for patients with malignant brain cancers.